LEAP Administrative Core

1. Abstract
The Administrative Core for the “Laboratory in Early Psychosis” Center, a.k.a. LEAP, will support the creation
of a research consortium spanning three major first episode psychosis clinics in Massachusetts and the
formation of a transdisciplinary team of leading researchers. The LEAP Center is dedicated to T2 translational
research in first episode psychosis, including analysis of the impact of specialized care, extensive multimodal
longitudinal data collection, and prediction and comparative effectiveness research to better understand
heterogeneity in patient outcomes and treatment effects. The Administrative Core will serve the Center’s goals
by facilitating regular communication, fostering synergy among disciplines, supporting training opportunities
and pilot projects, disseminating information on Center activities, organizing stakeholder panels, and
overseeing evaluation of the Center itself. The Core will be led by the Center Leads Drs. Öngür, Hsu, and
Hernan, and supported by a Center Administrator. The Core has four aims. First, it will oversee and coordinate
all activities essential to the functioning of the Center, including maintenance of regulatory and contractual
obligations, management of budgets and subcontracts, interacting with academic, state, and federal agencies,
completion of reporting requirements, supporting regular communication between Center elements, and
fostering and tracking collaborations. Second, the Core will oversee and coordinate governance structures
including the Steering, Manuscript, Data Management and Access, Pilot Project, and Training committees
within the Center. Third, it will manage the solicitation, review, funding, monitoring, and reporting of the conduct
of an average of two R03-level pilot projects each year. And fourth, the Administrative Core will coordinate and
manage engagement with a diverse array of stakeholders including patient and family groups, national and
state policy makers, payers, as well as a panel of senior scientific experts. The Core will also support
dissemination of Center activities and advances through conferences and short courses, visiting scholar series,
clinical case conferences, protocols and software, as well as a website intended to serve the general public.
Finally, the Administrative Core will track objective metrics of Center performance and convene annual
meetings of the Advisory Board (composed of senior investigators within and outside of psychiatry research
which will conduct assessments of Center progress and suggest refinements) as well as convene regular
meetings of the Center’s Faculty Panel, and Stakeholder Committees. Taken together, the Core activities are
designed to ensure that the LEAP Center becomes a unified whole that is greater than the sum of its parts.